Cell Electrophysiology Core

Cell Electrophysiology Core
Summary
The primary purpose for this core is to support infrastructure to provide
investigators in the neuroscience community in Delaware with access to
electrophysiological methods to answer their research questions. Cell electrophysiology
provides unique functional assessment and characterization of excitable cells, tissues
and ion channels. However, electrophysiological experiments require expensive,
specialized equipment, as well as years of time to develop the necessary technical skills for data collection and analysis,
and are therefore out of reach for laboratories that are not specialized in that area. This core was established as part of
our Phase II COBRE in response to a needs-assessment among the biomedical research community in Delaware that
identified a pool of 13 externally-funded researchers throughout the state who wanted to collect electrophysiological
data from their model systems, but lacked the means to do so. A survey of graduate students conducted at the annual
Delaware Neuroscience Symposium in 2018 found many would like to get some experience with cell electrophysiology
to expand the scope of their research projects and broaden their repertoire of techniques.
Support from our Delaware Center for Neuroscience Research COBRE and the statewide Delaware IDeA
Network of Biomedical Research Excellence (INBRE) enabled the purchase of electrophysiology instrumentation
supporting traditional patch clamp, multi-electrode array recordings, and automated patch clamp, ensuring state-of-
the-art instrumentation in the core. Our core will provide Delaware neuroscientists access to electrophysiological
techniques, experienced collaborators and consulting expertise that will increase the innovation and impact of their
research and make them more competitive for external funding. Continued support through a Phase III COBRE award
will allow broad dissemination of the availability of our CE Core, its instrumentation and services. By the end of our
Phase III award we expect that our CE Core will have measurable downstream impacts including increased numbers
of research publications and greater external funding at Delaware State University, an Historically Black university, as
well as across the state of Delaware. The increased level of research activity will provide new research and training
opportunities for undergraduate and graduate students both within the DSU and other institutions in Delaware.

Public health relevance
Delaware Center for Neuroscience Research Public Health Relevance Summary The foundation of Phase III proposal is Delaware’s expanding set of human and research resources in neuroscience, which has Delaware neuroscience research competitive on a national level. Our project supports research aimed at determining how thoughts, memories, feelings and actions emerge from dynamic activities in the brain and are changed over time; as well educational programs to develop a workforce that can participate in and benefit from advances in our understanding of brain function. An increased understanding of how the brain and nervous system functions will facilitate treatments for diseases and injuries and provide insights into human behavior, biases, and cognition.